Genomic Sciences Shared Resource

CORE 009 – GENOMIC SCIENCES SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The mission of the Genomic Sciences Shared Resource (GSSR) is to bring new and powerful genomics
approaches to the Vanderbilt-Ingram Cancer Center (VICC) research community, inclusive of our VICC members
and partners at Meharry Medical College, Tennessee State University, and other NCI centers. The vision of the
GSSR is to rapidly translate the most powerful modern and enabling genomics technologies to practice and
make these accessible to investigators. The GSSR seeks to maximize responsiveness to unmet scientific needs
and partner with VICC investigators to develop and operationalize new processes, platforms, applications,
assays and dry lab pipelines. To support investigators with their important work, the GSSR offers high level
scientific concierge support. This includes advice on appropriate technology, sample collection, processing and
extraction, biobanking and storage, and quality assessment. The GSSR offers project management and study
design to protect sample and data integrity, data management and analysis. The GSSR seeks continuous
improvement in quality, cost, scalability, and turn-around time, as well as an increase in the range of
assays/applications and sample types across both wet and dry laboratory phases. GSSR has found that the
need for genomic data analysis is increasing rapidly for many VICC investigators. Thus, over the next iteration
of the CCSG, the shared resource plans to increase bioinformatic support for users, including the processing of
data to deliver intermediate results (i.e. count table for RNAseq, variant calls for DNAseq, etc.) as well as provide
tools for analysis and visualization with ongoing high-level expertise provided in the GSSR. Importantly, the
GSSR supports researchers in the design of rigorous experimental approaches that are transparent and
reproducible. The GSSR accomplishes these goals through training, informal mentorship and service provided
by the core. The GSSR staff are particularly well suited to facilitating good experimental design and validated
methods, providing authentication services for key biological resources and in defining and establishing rigorous
methods for acquiring and analyzing genomic datasets.

Public health relevance
CORE 009 – GENOMIC SCIENCES SHARED RESOURCE PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Genomic Sciences Shared Resource.